Society of Behavioral Medicine 2019 Annual Meeting & Scientific Sessions

PROJECT ABSTRACT The Society of Behavioral Medicine (SBM) will hold its 40th Annual Meeting & Scientific Sessions from March 6-9, 2019, in Washington, DC. This application seeks funding in support of meeting programming addressing the following specific aims: (1) to train attendees in the skills necessary to effectively engage diverse stakeholders (e.g., patients, policymakers, community leaders, industry leaders) in their research to enhance the impact of behavioral medicine on individual and population health; (2) to provide guidance to attendees on how they can disseminate their research findings and scientific knowledge to larger audiences by leveraging new media and public speaking and writing opportunities, with the goal of increasing public awareness of the behavioral medicine field, disseminating evidence-based information about health promotion and disease prevention, and ultimately enhancing the impact of the field on public health; (3) to enhance the diversity of behavioral medicine professionals by providing mentoring, leadership training, professional development, and employment networking opportunities; and (4) to enhance the methodological rigor of behavioral medicine research by having expert-led discussions on clinical trial methodology, reproducibility, open science, and interdisciplinary collaboration to produce new theoretical models and methods. SBM is the nation’s leading scientific society dedicated to behavioral medicine, representing approximately 2,400 researchers and clinicians from more than 20 disciplines. SBM’s members include researchers, clinicians, educators, and industry professionals who focus on the development and integration of behavioral, psychosocial, and biomedical theory, knowledge, and interventions relevant to the understanding of health and disease. They work to understand, prevent, and treat chronic diseases such as cardiovascular diseases, respiratory diseases, diabetes, and cancer. They conduct research and translate findings into real-world settings to improve lives while also reducing healthcare costs. SBM’s annual meetings are the premier forum for disseminating behavioral medicine’s important ideas and breakthroughs. The meeting’s educational sessions, networking events, and exhibit halls facilitate exchange of information and ideas. Attendees apply the knowledge gained to disease prevention and management, and development of innovative research designs, effective interventions and strategies, and evidence-based policies. SBM meetings feature high-impact plenary speakers who present topics such as “Social Divides and Health Divides” (Sandro Galea, MD, MPH, DrPH, 2018). The 2019 SBM Annual Meeting will be attended by an estimated 2,100 individuals from the United States and abroad, featuring more than 1,500 presentations. The meeting theme is “Leading the Narrative, with sessions energizing attendees to communicate their science to the public and increase behavioral medicine’s visibility in public discourse about health. Most of our country's health challenges have behavioral origins, which makes this focus and SBM’s vision of “better health through behavior change” more important than ever.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) The Society of Behavioral Medicine’s 40th Annual Meeting & Scientific Sessions, to be held March 6-9, 2019, will bring together 2,100 of the nation’s leading behavioral scientists, clinicians, educators, and policymakers to exchange new research on improving health through behavior change, in particular via media and public outreach. Through a broad range of scientific presentations, discussions, and skill-building workshops, the meeting will facilitate the exchange of the latest population‐level, clinic‐based, and experimental research on the prevention and treatment of the leading causes of morbidity and mortality, with the goals of improving health behaviors, reducing the burden of chronic disease, lowering healthcare costs, and bettering our nation’s health.